Impact of nucleotide metabolism on bacterial clearance

Project Summary
In my laboratory, we study how host metabolism determines the outcome of infectious diseases, such as during
pneumonia. Pneumonia is a brisk inflammatory reaction to airway pathogens that, if not adequately regulated,
can predispose to infection by opportunists that exploit airway oxidation to persist, such as Pseudomonas
aeruginosa and Staphylococcus aureus, which belong to the feared family of multidrug-resistant ESKAPE
pathogens. In response to the oxidative metabolism of airway cells, these organisms activate many mechanisms
of virulence that favor their survival in the human lung, such as toxins and biofilms, which exacerbate the damage
of the respiratory mucosa. Although it is known how these opportunists exploit airway damage to persist, it
remains poorly understood how the host eradicates infections by controlling these pro-oxidant pathways. In the
5 years contemplated for this project, we will address how regulation of oxidative metabolism in airway cells
limits bacterial persistence, and how we can use this knowledge to design new therapies to eradicate pulmonary
infections by ESKAPE pathogens. Nucleotides, like purines and pyrimidines, are not only used by cells to
generate nucleic acids to grow, but also to supervise many physiological processes, such as inflammation.
Indeed, in many autoimmune diseases, anti-inflammatory nucleotide signaling is severely impaired, causing
tissue oxidation and mucosal damage. These strong anti-inflammatory properties of certain nucleotidic routes
are also exploited by tumors to evade host immunity. In order to suppress the activation of anti-tumor leukocytes,
malignant cells co-opt both dihydroorotate dehydrogenase (DHODH) and the ecto-nucleotidase CD73, which
are two major components of the de novo pathway of pyrimidine synthesis and the purine dephosphorylation
route, respectively. While the regulatory roles of DHODH and CD73 are well appreciated in cancer and
autoimmune diseases, their activities in other major inflammatory pathologies, like pneumonia, remains unclear.
Here, we will progress in the research line of my laboratory by establishing that nucleotide metabolism through
both DHODH and CD73 is critical in the protection of the host lung against pneumonia by P. aeruginosa and S.
aureus. We will demonstrate that both DHODH and CD73 limit the detrimental oxidative metabolism of airway
cells, thus preventing from activation of mechanisms of pathogenesis by ESKAPE opportunists that feed off lung
damage to cause disease, like toxin synthesis and biofilms. We will accomplish these goals by performing
transcriptomic and metabolomics analyses in the airway of infected both controls and DHODH/CD73-deficient
animals, in which we will measure the host and bacterial networks related with oxidative metabolism, host
immunity, and pathogen virulence. Thus, in this project, we will establish the impact of nucleotide metabolism in
lung health against pulmonary pathogens, which will provide us both a metabolic framework to better understand
the pathology of pneumonia and new targets to clear infection produced by these opportunists.

Public health relevance
Project Narrative Nucleotides, like pyrimidines and purines, do not only provide cells with nucleic acids for growth, but also function as signaling molecules that control tissue inflammation. Although the immunosuppressive role of certain nucleotides is well appreciated in cancer and autoimmune diseases, their relevance in other inflammatory pathologies, like pneumonia, remains unclear. In this project, we will establish that host nucleotide metabolism is critical to prevent from infection caused by pathogens that exploit lung inflammation to persist, like the feared ESKAPE opportunists Pseudomonas aeruginosa and Staphylococcus aureus.